Epigenetic regulation of sporulation in Clostridioides difficile

Clostridioides difficile is a major nosocomial pathogen that costs the US healthcare system ~$5 billion to treat
each year. Since the CamA DNA methyltransferase is important for infectious spore formation and persistence
in mice, and CamA is unique to C. difficile, elucidating the impact of DNA methylation on C. difficile physiology
could facilitate the development of new therapeutics.

Public health relevance
DNA methylation is a major mechanism for epigenetically regulating transcription in eukaryotes, but its role in regulating gene expression in bacteria has been under-appreciated in comparison. However, recent advances in methylome sequencing have revealed that the vast majority of bacteria methylate their DNA using orphan methyltransferases (MTases), which act independently of the restriction endonucleases that are typically paired with MTases in bacteria. While recent work indicates that orphan DNA MTases can modulate gene expression and important phenotypes like antibiotic resistance, biofilm formation, and virulence in diverse bacteria, the specific methylation sites responsible for epigenetically regulating a given phenotype remain unknown because MTases typically methylate thousands of sites in a given bacterium. However, identifying these sites is critical for precisely delineating how DNA methylation controls bacterial physiology. We previously showed that an orphan DNA MTase, CamA, enhances the formation of infectious spores and promotes the persistence of the bacterial pathogen Clostridioides difficile in mice. However, it was unclear which of CamA's 7,500 target sites was responsible for driving these phenotypes. Our recent preliminary work suggests that a single methylation site (termed Me3) in the promoter region of a gene encoding a key sporulation regulator, the SpoIIE phosphatase, is responsible for the sporulation defects observed in a ∆camA mutant. SpoIIE is required to activate the early-acting sporulation-specific sigma factor sF, and mutation of Me3 reduces the expression of spoIIE to the levels observed in a ∆camA mutant. Thus, this application will determine the functional significance of CamA-mediated methylation of Me3 in C. difficile. In particular, we will test the hypothesis that Me3 site methylation promotes spoIIE transcription and thus increases sF activation. Since sF activation commits sporulating cells to completing sporulation even if they are returned to rich media conditions in Bacillus subtilis, and since an Me3 site mutant exhibits less variation in its sporulation levels than WT C. difficile, we hypothesize that the epigenetic regulation of spoIIE transcription allows C. difficile to stochastically vary the proportion of cells that commit to completing sporulation and that this variation enhances C. difficile’s ability to persist in the host. To test these hypotheses, we will correlate the methylation status of Me3 with spoIIE expression, sF activation, commitment to sporulation, sporulation levels (including heterogeneity in sporulation levels) in strains with varying amounts of Me3 site methylation. To determine whether decreased sporulation drives the faster clearance of ∆camA from mice, we will also assess the effect of Me3 site methylation on the persistence of C. difficile in mice. Finally, we will determine the impact of reducing variability in spoIIE expression at the single-cell level on the ability of C. difficile to persist in the host. Collectively, these analyses will reveal how a single methylation site can control cell fate decisions and persistence in a host.